PRECISE (PeRfusion imaging to identify postErior CIrculation candidateS for thrombectomy)

PROJECT SUMMARY .
Acute ischemic stroke is the leading cause of disability in the United States and the second-leading cause of
death worldwide. AIS that involves a major cervical or cerebral artery is termed a large vessel occlusion, and
recent landmark randomized studies found that endovascular thrombectomy is an effective treatment for
ischemic stroke caused by large vessel occlusion of the internal carotid, middle, or anterior cerebral arteries
(anterior circulation). However, up to 15% of large vessel occlusions occur in the vertebral or basilar arteries,
and these posterior circulation stroke patients were largely excluded from modern endovascular thrombectomy
trials. Clinical outcomes in patients with vertebral or basilar artery occlusions are often poor with severe
disability or death occurring in 30-54% and 36-86% of patients, respectively. There are no prospective or
randomized data designed to determine which imaging strategies should be used to guide thrombectomy
treatment decisions in this understudied population.
PRECISE (PeRfusion imaging to identify postErior CIrculation candidateS for thrombEctomy) is a prospective
cohort study of patients with acute ischemic stroke due to occlusion of the vertebral or basilar artery within 24-
hours of symptom onset. Patients will undergo CT or MRI cerebral perfusion imaging prior to endovascular
thrombectomy treatment. The results of this study will determine if cerebral perfusion imaging can identify a
subset of patients who are most likely to have a favorable outcome after thrombectomy treatment. PRECISE
has the potential to improve the imaging evaluation of patients with acute ischemic stroke of the posterior
circulation, to provide valuable prognostic information regarding thrombectomy efficacy in these patients, and
to define sub-groups of patients who might benefit from future neuroprotective strategies.

Public health relevance
PROJECT NARRATIVE . Acute ischemic stroke caused by occlusion of the vertebral or basilar arteries is a devastating disease that results in high rates of death and disability. Patients with vertebral or basilar artery occlusions often undergo endovascular thrombectomy treatment to restore blood flow in these vessels, which is thought to improve the chances of a good outcome in these patients. The goal of PRECISE is to determine if advanced cerebral perfusion imaging can identify a subset of patients with vertebral or basilar artery occlusion who are more likely to benefit from endovascular thrombectomy. The results of PRECISE will improve our ability to identify patients for emergency thrombectomy and may lead to improved patient selection and prognostication in this understudied stroke population.